Predicting Outcomes for Uterine Fibroid Embolization by using Deep Learning of Paired MRI Scans

PROJECT SUMMARY
Uterine fibroids represent the highest prevalence of benign tumors in women, with reports ranging anywhere
from 4.5% to 68.6%, with a significant bias towards African American women. It is estimated that the economic
burden on the healthcare system from symptomatic women with uterine fibroids is up to $34 million.
Currently, uterine fibroid embolization (UFE) is considered a highly effective minimally invasive procedure
with up to an 85% success rate. However, hysterectomies are the most commonly performed procedures,
accounting for nearly 600,000 annually, while only 14,000 UFE procedures are performed annually. It has been
well documented that minorities are less likely to be referred for minimally invasive procedures, even though
there is universal insurance coverage for them. Furthermore, women in lower socio-economic status, particularly
African Americans, have been disproportionately referred for open surgery. Therefore, automated tools, like the
ones in this proposal, that can provide unbiased referrals will be significant advantage at combating this
unfortunate bias.
This proposal will specifically explore the use of machine learning and deep learning methods to leverage a
novel retrospective dataset that compiles features extracted from paired pre-operative and post-operative
magnetic resonance imaging (MRI) scans of up to 700 patients who underwent a UFE. These models will provide
a UFE treatment effectiveness score that will provide an objective and quantitative metric to decide whether a
patient is good candidate for UFE.
The short term impact of this proposal will be the creation of a curated database of paired UFE MRI scans
that have been analyzed for various metrics regarding fibroid positions and patient characteristics, that will allow
the clinical community to begin providing quantitative methods to determine UFE candidates. The long-term
impact of this proposal will be realized in subsequent clinical trials that validate these AI models properly to
predict which patients should be leveraging UFE as a non-surgical alternative for treating fibroids.

Public health relevance
PROJECT NARRATIVE The overarching goal of this proposal is to determine which patients are the best candidates for uterine fibroid embolization (UFE) by creating unbiased algorithms that determine the likelihood of treatment effectiveness based on a pre-operative magnetic resonance imaging (MRI) scan. This tool will be particularly impactful for patients from minority populations who are disproportionally neglected as candidates for this non- invasive and cost-effective treatment.